BLRD Research Career Scientist Award Application

Project Summary/Abstract
The overarching goal of Dr. Freeman’s research has been to understand how alterations of the
genome/epigenome contribute to aging and how therapies could potentially target these changes to maintain a
‘youthful’ epigenome that retards aging, delays/prevents age-related diseases, and improves the health and
quality of life of the elderly. Epigenetic dysregulation is a hallmark of aging, but exactly how this contributes to
cellular dysfunction and disease is not known. To elucidate this contribution, Dr. Freeman’s VA research has
focused on epigenomic regulation in astrocytes, microglia, and neurons in the hippocampus with aging. Using
novel cell isolation and advanced sequencing approaches, cell-type specific base resolution maps of both
methylation (mC) and hydroxymethylation (hmC) in CG and non-CG contexts are being generated. With paired
RNA expression data, bioinformatic techniques are being used to understand the regulation of gene expression
with aging. This type of base-specific, genome-wide, and cell-type specific studies have not been performed in
aging research and will potentially offer the most in-depth view of epigenomic changes with aging to date.
Further, to demonstrate the prevention of age-related epigenomic changes, caloric restriction is being used. In
total, these studies will not only increase the understanding of the neuroepigenomics of aging but also provide
targets for future interventional studies using epigenome editing. Importantly these studies examine both males
and females to provide sex-informed insight as his prior studies have demonstrated that the majority of age-
related epigenomic changes are sexually divergent.
Dr. Freeman is also PI or co-PI on three NIH projects and one foundation funded project. These studies extend
his VA research in aging through use of novel transgenic mouse models and anti-aging interventions in the brain,
retina, and GI system. These models developed by his lab allow temporally controlled, cell-type specific tagging
of nuclei and ribosomes to isolate DNA for epigenomic analysis and RNA for expression analysis without the
need for cell sorting. In the brain and retina, heterochronic plasma transfer, in which plasma from young mice is
administered to old mice for rejuvenation, is being used to determine if age-related epigenomic changes can be
reversed after they have occurred. In parallel, using proteomic approaches, DNMT and TET interacting proteins
are being identified that target them to specific genomic regions for epigenomic alteration.
More broadly, Dr. Freeman also has an extensive collaborative portfolio with other OKC VAMC investigators. In
these VA and NIH funded studies, Dr. Freeman is examining cell-type specific mechanisms of aging in muscle,
brain, ovary, joints, and colon. In addition to bringing molecular and biochemical expertise to these studies, a
common thread of epigenetics of aging allows comparisons and contrasts to be made across the organ systems.
These collaborations are paired with his work as Director of the Genomics Sciences Core of a recently renewed
P30 NIA Center grant: the Oklahoma Nathan Shock Aging Center. This core provides epigenomic and
transcriptomic analyses as well as mitochondrial genomic assays for aging researchers across the country.
Additionally, Dr. Freeman leads many cross-institution (OMRF, OUHSC) initiatives focused on trainee and faculty
development, including training students and post-docs (F-Troop) and junior faculty (NeuroGrant Seekers) in
successful preparation and submission of grants. He has also worked with leaders at the OKC VAMC to help
recruit new, highly successful investigators to the VA system, one of which has received a MERIT award with
three more investigators having MERIT applications currently under review.

Public health relevance
Project Narrative: Aging is the principle risk factor for a number of conditions, including cognitive decline, Alzheimer’s, vision loss, cancer, and sarcopenia, all of which are critical issues in older veterans. As a fundamental regulator of cell function and identity, epigenetics may be a key driver of the aging process and a point of treatment to promote systemic healthy aging. Modern biological tools now allow for the elucidation of epigenomic changes across tissues and cell types within tissues. Dr. Freeman’s studies seek to understand these epigenetic processes using novel analytical approaches and animal models, complemented by advanced bioinformatic analyses. Through his collaborations, he also seeks to advance the research and training missions of the VA, extend basic biological knowledge, and identify targets for potential therapeutic manipulation. As a mentor to trainees and junior faculty, Dr. Freeman has initiated successful programs to aid junior colleagues in developing, submitting, and receiving research funding to advance their training and research.